Equipment Supplement: New Amine-Acid Couplings and their Impact on Medicinal Properties

NOT REQUIRED: No proposed changes for proposed supplement.

Public health relevance
Project Narrative Our research centers on the repurposing of broadly available amines and carboxylic acids towards products that complement the classic amides produced with these two popular building blocks. This building block repurposing strategy is particularly valuable in drug discovery since the identification of novel catalysts and reaction conditions can enable the rational manipulation of physicochemical drug properties. The current proposal describes the accelerated discovery of such novel amine–acid methods through access to a modern ultra-performance liquid chromatography (UPLC) instrument with multiple chromatographic columns for rapid separation.